Effects of Fish Oil ± Salsalate on the Omega-3 Index and the Circulating Lipodome of Omega-3 Polyunsaturated Fatty Acid Metabolites in Patients with Type 2 Diabetes and Diabetic Neuropathy

Peripheral neuropathy, the most prevalent chronic complication of diabetes may affect up to 50% of
patients and critically contributes to increased pain and risk of amputations, lower physical
functioning, increased daily living burden, reduced quality of life, increased health care costs, and high
mortality risk. Although intensive glucose control was shown to delay the onset and progression of
diabetic peripheral neuropathy (DPN) in patients with type 1 diabetes, similar evidence is not available
for the very vast majority of patients who have type 2 diabetes (T2D). In spite of continuous research
a disease modifying therapy to reverse human DPN is still not available. Work in our laboratories has
provided evidence that omega-3 polyunsaturated fatty acids (PUFA) found in fish oil in combination
with salsalate may be an effective treatment for DPN. Our pre-clinical studies have shown that fish oil
and salsalate slows progression of DPN and initiates nerve damage repair and reverses DPN . We
have also demonstrated that E and D series resolvins, metabolites of eicosapentaenoic acid (EPA)
and docosahexaenoic acid (DHA), respectively, reverses DPN to a similar extent as fish oil. These
data provides the rationale to advance the fish oil-salsalate combination to DPN clinical trials. The
studies proposed in this application are the first step in this endeavor. Using participants with T2D and
DPN we will initially establish the most efficient dose of fish oil that will increase the omega-3 index
(defined as the sum of EPA and DHA, as a percentage of total fatty acids in red blood cells) to at least
8 – 12% presumed to be therapeutic. Next, we will combine fish oil and salsalate to examine their
effect on the production of pro-resolving metabolites derived from EPA and DHA. We hypothesize that
fish oil in a concentration dependent manner will increase the omega-3 index to therapeutic levels
independent of salsalate. We also hypothesize that combining fish oil and salsalate vs. fish oil alone
will more effectively increase the circulating pro-resolving mediators of omega-3 PUFA and reduce
markers of inflammation to a greater extent than fish oil alone. The lipidomics of omega-3 PUFA in
human subjects has been understudied and not at all in subjects with diabetes and DPN. Limited
studies in normal human subjects taking fish oil have demonstrated considerable variability in
circulating levels of omega-3 PUFA and this variability could have an impact on their metabolic fate.
The studies proposed will address this limitation and guide us in selecting the most effective and safe
combination dose of fish oil and salsalate for increasing the omega-3 index to a therapeutic level and
maximize production of pro-resolving lipid mediators. This will lead to design of a disease modifying
trial for DPN, with the potential to improve the quality of life for all patients with diabetes. The excellent
safety profiles of fish oil and salsalate make them an attractive choice for long-term clinical use.

Public health relevance
Peripheral neuropathy (PN) is a major complication affecting about 50% of the diabetes population with symptoms ranging from pain, numbness, paresthesia and ulceration in the extremities it is also the major cause of non-traumatic amputations. Besides pain management the only option physicians have to slow progression of PN is glycemic control but in type 2 diabetes even good glycemic control is ineffective. Our pre- clinical studies have focused on discovery of an effective treatment and have identified the combination of omega-3 polyunsaturated fatty acids (fish oil) and salsalate as a potential candidate, however; before clinical trials can be initiated we need to have a better understanding of the most effective dose of omega-3 polyunsaturated fatty acids and salsalate that will increase the omega-3 index to a healthy level and maximize the formation of pro-resolving metabolites in diabetes subjects with PN.